Epidemiological Analysis and Causal Modeling of Non-AIDS-Defining Skin Cancers in People with HIV

PROJECT SUMMARY/ABSTRACT
This application seeks to understand the epidemiological patterns and complex interplay of risk factors
driving skin cancer incidence and severity among people with HIV (PWH) and to develop predictive tools that
address disparities in diagnosis and prognosis. PWH face a higher likelihood of developing non-AIDS-defining
skin cancers (NADSCs), including but not limited to basal cell carcinoma, squamous cell carcinoma, and
melanoma, due to multifactorial biopsychosocial determinants of health. Despite this risk, the mechanisms
underlying NADSC incidence and severity in PWH remain under-researched, and no tailored predictive models
exist to guide targeted interventions for this vulnerable population.
This proposal describes the application of epidemiological and machine learning approaches, including
causal artificial intelligence (AI) methods, specifically probabilistic graphical models (PGMs), with two
objectives: 1) characterizing patterns of NADSC burden among PWH and 2) identifying direct effectors among
risk factors contributing to NADSC in PWH and developing robust predictive models accordingly. By leveraging
multimodal healthcare data containing sociodemographic and clinical data, I aim to address critical gaps in the
identification of high-risk subgroups and the development of targeted detection and prevention strategies.
The central hypothesis of this proposal is that NADSC incidence and severity in PWH are influenced by a
complex interplay of causal factors that can be modeled to inform personalized clinical interventions. In Aim 1, I
will characterize the epidemiological patterns of NADSC burden (prevalence, disease sub-types, severity)
among PWH compared to people without HIV. In Aim 2, I will identify factors that directly affect NADSC
incidence and severity in PWH. Specifically, I will integrate high-dimensional data sources to uncover
interactions between risk factors such as immunosuppression, comorbidities, medication history, and
sociodemographic identifiers. I will then build and validate predictive models for NADSC incidence and severity
among PWH, focusing on the integration of multimodal data to develop robust and clinically actionable models.
These models will be validated using an independent dataset to ensure generalizability.
This work is significant because it addresses a critical gap in understanding and predicting NADSC
incidence and severity in PWH, a population with unique sociomedical vulnerabilities. The project is innovative
in its use of causal AI and multimodal data to elucidate novel relationships and create predictive tools tailored
to the needs of PWH. These findings will advance the field of onco-dermatology and contribute to reducing
disparities in skin cancer outcomes through data-driven clinical and public health strategies.

Public health relevance
PROJECT NARRATIVE People with HIV (PWH) face an increased likelihood of developing non-AIDS-defining skin cancers (NADSCs), yet the mechanisms driving this increase remain poorly understood. This proposal aims to assess epidemiological patterns, uncover the interplay of causal factors underlying NADSC incidence and severity in PWH, and develop predictive models to guide early intervention and personalized care. These findings will inform efforts for skin cancer prevention, detection, and treatment, addressing critical health disparities in this vulnerable population.